DETERMINATION OF OPTIMAL TREATMENT OF N5,N10 METHYLENE TETRAHYDROFOLATE

A patient is being monitored monthly to determine the optimal dose and interval of betaine administration, minimal effective dose of folate and necessity of supplementation with carnitine and/or methionine to correct biochemical and clinical abnormalities.